The role of networks and serious illness in Medicare Advantage disenrollment

Project Abstract
Enrollment in Medicare Advantage (MA), the privatized segment of the Medicare program, has rapidly
increased with roughly 50% of Medicare beneficiaries enrolling in an MA plan. Under the MA program, private
plans are paid risk-adjusted capitated payments to deliver the Medicare benefit. These plans have discretion to
implement utilization management tools and narrow provider networks to control costs. Beneficiaries enrolled
in MA receive benefits not available in traditional Medicare (TM) including out-of-pocket maximums and
supplemental benefits (e.g., vision and dental coverage). However, enrollees must remain in their plan’s
network to avoid higher out-of-pocket costs. These restrictions could pose barriers to accessing care for
beneficiaries who have serious illnesses. As the MA program continues to grow in popularity, a more medically
complex population of beneficiaries is opting to participate in the program.
The overall objective of this grant is to investigate aspects of the MA program that likely pose problems
for beneficiaries with serious illness: plan networks for skilled nursing facilities (SNFs) and oncology care
networks. Aim 1 describes the breadth and quality of SNFs using novel 2022 data on MA plan networks from
Ideon (formerly Vericred). We hypothesize that plans will limit access to high quality SNFs and include low or
average quality SNFs in network. Aim 2 uses 2019-2020 Surveillance, Epidemiology, and End Results (SEER)-
Medicare data linked to Ideon data to examine the association between breadth of oncology networks and
disenrollment from MA to TM or switching to a new MA plan for patients newly diagnosed with cancer. We
hypothesize that being in a plan with limited access to specialized cancer centers will be associated with an
increased probability of leaving one’s MA plan for TM or a new plan. Aim 3 uses a difference-in-differences
study design to estimate the effect of the lengthening of the Medicare Advantage Open Enrollment period on
rates of MA plan switching or exits to TM for patients newly diagnosed with cancer. We use 2016-2019 SEER-
Medicare data and hypothesize that the longer enrollment periods will lead to increased rates of plan
disenrollment for patients newly diagnosed with cancer.
All together the results from these aims will provide added evidence on how networks contribute to poor
patient experience in MA, particularly for beneficiaries with serious illnesses. We aim to contribute evidence on
how restricting access to care and limiting plan enrollment choices impacts patients with serious illnesses like
cancer.

Public health relevance
Project Narrative We use novel data on Medicare Advantage (MA) networks to investigate skilled nursing facility network breadth and to study whether oncology network breadth is associated with plan disenrollment. We also examine whether measures that allow beneficiaries more time to opt out of their plans led to greater Medicare Advantage disenrollment among patients with cancer. Taken together this work will investigate whether the MA program fully meets the needs of patients with serious illnesses, especially in terms of access to key services.